Nephrogenesis on a chip: an simple modular platform to spatially pattern extracellular matrix, stromal cells, and soluble factors

Abstract
It is well appreciated that the spatial organization of the biophysical and biochemical cues in the extracellular
matrix (ECM) in concert with the stromal cell organization along the cortical-medullary axis of the developing
kidney is vitally important to nephron development. These insights have been obtained from animal and organoid
models, however, the exact mechanisms behind the tightly regulated spatial and temporal differentiation and cell
specification have not been fully established. Although reductionistic, an in vitro microphysiological system (MPS)
offers a platform that allows recapitulation and control of the developing kidney's critical structural and functional
components. Here, we develop an easy-to-use modular 3D model of the developing nephron in which the
biophysical and biochemical cues of the ECM, soluble factors, and stromal cell identity can be spatially patterned
along the length of an epithelialized tube (Aim 1). In Aim 2, we will create a framework for MPS fabrication and
model establishment to enable wide distribution and technology transfer to other labs that are established experts
in investigating different aspects of nephrogenesis and renal pathology but non-experts in using microfluidic in
vitro models. This easy-to-use system will provide researchers without MPS expertise with a tool to investigate
the role and mechanisms of biochemical, cell-cell, and cell-ECM interactions during nephrogenesis. As such,
this model will be designed to be quickly and easily disseminated to the research community to rapidly increase
mechanistic investigation of nephrogenesis for biological understanding, pharmacological screening, and tissue
engineering applications.

Public health relevance
Narrative The functional units of the kidney, the nephrons, are established during development and do not regenerate later in life resulting in kidney failure after injury, disease, or age with the only cure being kidney transplant. Here we develop an easy-to-use modular 3D model of the developing nephron in which the biophysical and biochemical cues of the ECM, soluble factors, and stromal cell identity can be spatially patterned along the length of an epithelialized tube. This model will be designed such that it can be easily disseminated to the research community to rapidly increase mechanistic investigation of nephrogenesis for biological understanding, pharmacological screening, and tissue engineering applications.